Structural basis of the gating mechanism of connexin 26 and related hearing loss

SUMMARY
Connexin 26, as a gap junction channel, directly regulates the cell-to-cell exchange of ion,
metabolites, and second messengers. Mutations of connexin 26 can cause severe hearing loss.
However, the molecular gating mechanism on the structural basis of connexin 26 is still unclear,
especially the closed state and malfunction of connexin 26 mutations. We have developed the
native cell membrane nanoparticle (NCMN) system for high-resolution single-particle cryo-EM
structure determination and functional studies of membrane proteins within their physiological
conditions. We recently solved the cryo-EM structures of connexin 26 in the absence or presence
of calcium ions in an open state at 2.3 Å and 2.9 Å associated with about 36 lipid molecules via
the NCMN system. However, the close state of connexin 26 with high resolution is still uncovered.
We hypothesize that our NCMN system's application to structure determination of Cx26 and
Cx26-R75W in the presence and absence of calcium and calmodulin can provide unique
structural information. Aim 1: To investigate the CLOSED conformation of the gating mechanism
of Cx26. Aim 2: To elucidate the molecular basis of how the single point mutation R75W in Cx26
leads to profound hearing loss. The proposed experimental results will provide insights into
detailed structural information and biochemical analysis in understanding the gating mechanism,
also provide mechanistic details on abnormal channel gating function detected in this hearing
disorder. The structural information may lead to some novel strategy to modulate the malfunction
CX26-R75W for hearing loss.

Public health relevance
Single amino acid mutation of the connexin 26 membrane protein channel can result in hearing loss. To understand the gating mechanism and structural basis of the connexin 26 related hearing loss, we plan to determine high‐resolution structures of connexin 26 and its mutant in multiple functional states with single‐particle cryo‐EM.